Task A88: Cotton Rat Model for the Evaluation of Vaccines and Therapeutics for RSV and Related Viruses

This contract provides for the development of new and refinement of existing models of infectious diseases and may include evaluation of candidate countermeasures.